Administrative Core

We are building a multidisciplinary, thematic center in Aging and Regenerative Medicine. This goal will be
advanced by solidifying our cadre of dedicated young scientists to populate this area. It will also benefit from
the further development and sustainability of our Genomics, Bioinformatics, and Molecular Imaging Core to
support research in the center. The overall objective of the Administrative Core is to provide an efficient and
effective organizational structure to ensure good management, integration, and oversight of our COBRE
program. This will be achieved by our team of COBRE director, project coordinators, senior mentors, core
leaders, other steering committee members, and external advisory committee members. The success of their
efforts will be facilitated by our COBRE administrator. These individuals are part of a carefully crafted
framework that has as its focus the support and nurturing of our pilot project awardees, as they are guided in
their development as independent researchers. This supportive environment is created by ensuring the
formative and summative evaluation of the progress of these faculty, and the explicit communication of the
expectations placed upon them. Importantly, Phase III will involve a consolidation of research directions that
will involve, among others, incentives to incorporate the cutting-edge technologies that our scientific core
provides. This, in turn, will enhance the impact of the research and contribute substantially to the sustainability
of our center. Thus, we will: (1) Provide skilled personnel for effective fiscal and administrative management of
all components of the COBRE program. (2) Ensure that the Pilot Projects Program generates vision and
guidance to pilot project investigators in relation to programmatic and career development. (3) Assure the
programmatic relevance and sustainability of our Genomics, Bioinformatics, and Molecular Imaging Core
through ongoing assessment and evaluation that includes input from stakeholders. (4) Review the scientific
accomplishments of the pilot project investigators and the status of the overall center research program under
the direction of the Steering Committee, seeking guidance from our External Advisory Committee, to construct
effective means to resolve weaknesses. (5) Provide the interface with IDeA program staff for optimal
achievement of program development and long-term goals of this COBRE program. To achieve additional
cohesion, we are continuing mechanisms such as our seminar series that are designed to attract our
investigators, keep them engaged, and to encourage collaborations.